University of Arizona-Banner Health Mountain Consortium

The All of Us Research Program (AoURP) awardee, the University of Arizona (UArizona)-Banner Health, has established a productive and beneficent consortium to generate participation of individuals from all walks of life based on our Precision Engagement and Participant Journey models. Our successes include enrolling 88,000+ participants across Arizona, Colorado, and Wyoming. Our team achieves innumerable wins via sustained, reliable participant recruitment and protocol execution. To promote participation from populations that have not been extensively studied in precision health, the UArizona-Banner Health AoURP staff develop person-first, age-appropriate strategies to engage, enroll, and retain participants, and partner with community-based organizations. The UArizona-Banner Health consortium has contributed successfully to the early Pediatric Pilot phase A, and is currently enthusiastically contributing to Phase B. From this foundation, we will evolve and innovate over the next year and continue to reach our pediatric communities and contribute our expertise to the progression of national Pediatric enrollment efforts.
Accordingly, we propose to engage, enroll, and retain participants who reflect our population vibrancy nationwide by leveraging best practices and lessons learned during our previous seven years of experience. In the new funding cycle, we will focus on Pediatric and Family activities, support AoURP priorities, and meet evolving challenges. Four specific aims will address Year-2 Project Milestones and Deliverables, 1. Develop processes and timelines to Maintain regulatory requirements; 2. Contribute to the breadth and depth of the AoURP Pediatric dataset by enrolling 1,114 participants; 3. Implement a Pediatric engagement program that focuses on maintaining meaningful, lasting relationships with individual participants and families, community-specific partners. 4. Continue to provide high-quality and timely EHR data, maintaining rates of data transfer and conformance above 90%. The UArizona-Banner Health AoURP team will continue to exceed these goals and maintain our commitment to excellence.

Public health relevance
The All of Us Research Program has enrolled over 860,000 participants, and nearly 750,000 have completed the initial steps of the program, building a national research dataset that is unprecedented in size and scope to advance precision health. This project aims to further expand the databased through the enrollment of pediatric participants and their families. Studying children in longitudinal cohorts is of great importance, as there is much to learn from conditions that are often diagnosed in childhood. This expansion will further researchers’ capacity to utilize All of Us data for scientific discovery for individuals of all ages. The proposed research is relevant to public health because it has the potential to accelerate biomedical research, generate new knowledge, and reduce the public health burden of a wide variety of conditions affecting all Americans. Thus, the proposed projects are relevant to the part of the NIH mission that pertains to a focus on improving population health and supporting rigorous, reproducible, and unbiased research.